HIV Tat and alcohol-mediated activation of astrocytes involves ER stress/NLRP6 inflammasome axis

Project summary:
Despite combined antiretroviral therapy, HIV proteins like Transactivator of Transcription (Tat) persist at low
levels in the brains of HIV-infected individuals, resulting in cognitive decline collectively referred to as HIV-1-
associated neurocognitive disorders (HAND). Alcohol use disorder is a common comorbidity in people living with
HIV (PLWH) and is also known to potentiate the pathogenesis of HAND. Although the mechanisms underlying
HAND are complex and remain poorly understood, low-level, persistent neuroinflammation has been shown to
be a correlate of HAND. In the brain, glial cells such as the astrocytes, are major contributors of inflammation,
involving the inflammasome NLRP6 (a member of the NLR [nucleotide-oligomerization domain-like receptor)
family of proteins that acts as a sensor protein and plays multiple roles in regulating inflammation and host
defenses.
Based on the premise that alcohol use exacerbates HIV-associated neuroinflammation, we
hypothesize that exposure of HIV Tat stimulated astrocytes to alcohol will lead to exacerbated expression of a
pro-inflammatory milieu compared to cells exposed to either agent alone or to control cells (HIV protein/drug
naïve) and, further that mechanistically this involves increased activation of NLRP6 and its downstream signaling
pathways. In fact, our exciting preliminary studies have demonstrated that human A172 astrocyte cells exposed
to both HIV Tat (surrogate of HIV infection) and alcohol significantly increased the activation of NLRP6 involving
endoplasmic reticulum (ER) stress. The proposed hypothesis will be tested in two aims: SA1 To investigate the
molecular mechanism(s) underlying HIV Tat and ethanol-induced astrocytic activation in mouse primary
astrocytes (MPAs) and SA2. To validate the findings from SA1 in an in vivo doxycycline-inducible transgenic Tat
(iTat) mice model exposed to ethanol These findings could have important implications for the future
development of therapeutic interventions aimed at mitigating neuroinflammation in PLWH with HAND and alcohol
use disorder.

Public health relevance
Project Narrative: This project aims to investigate how alcohol potentiates HIV-associated neuroinflammation involving the inflammatory mediator, the inflammasome NLRP6, that is primarily expressed in the brain astrocytes, in the context of both HIV and the comorbidity of alcohol use. The mechanism(s) underlying this interaction remains poorly understood. Findings from this project could set the stage for the future development of targeted adjuvant therapeutics aimed at mitigating neuroinflammation in people living with HIV with alcohol use disorder.